Homemaker Home Health Aide Use and Veteran-Centered Outcomes

PROJECT SUMMARY. Persons with substantial functional disabilities--multiple limitations in activities of daily
living (ADLs)--overwhelmingly prefer to remain at home. The VA faces a crisis in providing care for such Veter-
ans, with increases in demand for long-term services and supports (LTSS) from 9.8 million older Veterans and
one million younger injured post-9/11 Veterans. VA must by law provide nursing home care for Priority 1A and
≥70% service-connected Veterans, and also provide Home and Community-Based Services (HCBS) for all Vet-
erans who qualify clinically. Although the law states LTSS must be provided in the least restrictive setting possi-
ble, there is evidence that HCBS is underused/ VA still spends over two-thirds of its total LTSS budget on insti-
tutional care, and GAO reports have identified persistent access barriers. Furthermore, our team found that only
50% of Veterans in Durham referred to HCBS used any services within a year. Underuse of HCBS poses a
significant clinical care problem by failing to meet Veteran preferences and needs and may accelerate disabling
events and costly institutionalization. And yet, we do not know the extent to which HCBS is underused, why it is
underused, and the consequences of current use patterns. Shedding light on this question requires knowledge
of the clinic, VAMC, and area-level factors that drive HCBS supply and demand. Evidence is thin because exist-
ing studies were limited to identifying Veteran factors predicting HCBS use. To our knowledge, no studies have
examined multi-level drivers of VA HCBS use among those referred, in particular, clinic-level drivers. Clinic struc-
ture and processes will differ and while involvement of clinic social workers is expected to be vital given their role
in making HCBS referrals, some clinics may have higher capacity for care coordination and routing of referrals.
Additionally, VAMC and area factors may constrain HCBS use through LTSS funding choices, wait list rules,
narrow networks, or workforce shortages. Homemaker home health aide (H/HHA) services will be our use case
because H/HHA is the largest HCBS program (163,639 unique users in FY22) and, like most HCBS, is delivered
through contracted providers. VA employees refer to H/HHA and care is provided by non-VA employees from
community home health agencies. A rigorous mixed methods study is needed to illuminate multi-level drivers of
H/HHA uptake and whether identified drivers reflect access supply barriers, Veteran preferences, or both. We
also need to understand impact of H/HHA on Veteran-centered outcomes, using causal inference methods. We
will address three inter-related aims: Aim 1. Identify multi-level drivers of any H/HHA uptake by 8 weeks (and 6
months) of referral compared to those with no H/HHA uptake by 8 weeks (and 6 months) among all newly referred
Veterans nationally 2017-2020. H1. Veterans w/ pre-referral exposure to outpatient clinic social workers will be
more likely to use H/HHA than Veterans with no pre-referral exposure to outpatient clinic social workers. H2.
Veterans assigned to primary care providers in clinics w/ high use of geriatric principles will be more likely to use
H/HHA than similar Veterans in other clinics. H3. Veterans at VAMCs and areas w/ favorable H/HHA climates
(more HCBS spending) will be more likely to use H/HHA than Veterans facing unfavorable climates. Aim 2.
Identify best practices that can be disseminated across VA through ~80 interviews w/ leaders, community home
health agency administrators, H/HHA coordinators, clinic staff, Veterans and caregivers about their perspectives
on structure, process, and preference factors influencing H/HHA use and timing at 3 high and 3 low-uptake sites
w/ diverse populations. Aim 3. Among Aim 1 referred Veterans, estimate the average treatment effect of earlier
(≤8 weeks) versus later (>8 weeks-6 months) versus no H/HHA use on person-centered Veteran outcomes and
VA total costs of care. H4. Earlier H/HHA use will lead to: i) delays in disabling events (injurious falls); ii) better
quality of life (more home time; less nursing home use); iii) lower total VA costs, compared to later uptake or no
uptake. This knowledge will enable our VA operational partners to define best clinic practices, optimal staffing
and network sizes, and community partnerships required to deliver H/HHA to Veterans who want and need it.

Public health relevance
PROJECT NARRATIVE. Persons with functional disabilities overwhelmingly prefer to remain at home. Home and Community-Based Services (HCBS) are an important support to help Veterans age in place, but government reports reveal HCBS access barriers for qualifying Veterans and show 50% of Veterans referred to HCBS do not use services within 12 months. We do not understand how supply constraints such as lack of access versus demand constraints such as preferences affect HCBS use nationally, nor the consequences of use patterns for Veteran-centered outcomes. This rigorous mixed methods study will illuminate multi-level drivers of the largest VA HCBS, homemaker home health aide services (H/HHA). We will also estimate the average treatment effect of H/HHA on Veteran-centered outcomes and total VA costs. This IIR will inform future scalability of H/HHA by obtaining perspectives from multiple parties about suboptimal use and use implementation mapping with our operational partners to recommend actionable change to the H/HHA benefit.